Initial Animal Validation of a Multimodal Molecular Monitor for Heart Failure Treatment

Project Summary
Recently the STRONG-HF trial exceeded initial expectations by demonstrating that heart failure re-admissions
can be reduced by 44%, and patients can be up-titrated on their medications remarkably faster, but only by
increasing the number of outpatient visits by four to monitor key molecular biomarkers such as NT-proBNP and
potassium. Given the strain already on the health-care system, a major need that has been directly requested by
cardiologists is to achieve STRONG-HF outcomes but in a more decentralized care format. If STRONG-HF care
can be implemented in largely ambulatory/home setting, it could represent the next largest leap forward in the
management of newly diagnosed heart failure. Kilele Health has performed rigorous discovery work to confirm
strong significance for remote post-discharge monitoring of heart failure patients: in interviews of 20
cardiologists 100% cited value for remote monitoring of NT-proBNP for treatment efficacy and 90% cited value
for remote monitoring of potassium for adverse events caused by treatment. Kilele Health’s goal is to develop
a factory-calibrated continuous multi-modal molecular monitor of NT-proBNP and potassium for heart failure
patients during the first 30-90 days after discharge. Kilele’s investor-vetted financial modeling points to a $4.1B
market opportunity in heart failure alone. For comparison, this is even larger than the initial beach-head market
for glucose monitors in Type 1 diabetes ($2.6B). The proposed device is highly innovative, as it would be the
first ever continuous molecular monitor for cardiovascular diseases. Continuous remote molecular monitoring
will shift current clinical practice, with automatic data to the patient and to electronic health-care records, not
only improving patient outcomes (greater accuracy, more timely) but reducing the enormous $16B annual costs
of heart failure readmissions. The investigators are exceptionally prepared due to their recent breakthroughs
in creating robust aptamer sensors for molecular monitoring, existing relationships with glucose monitor
companies, enagement with clinical experts in cardiovascular disease, and due to decades of experience for
Kilele’s leadership in commercializing diagnostic devices. The team will achieve the Phase SBIR 1 overall
objectives through the following three aims: Aim 1 – create a skin-insertable sensor strip that can measure both
NT-proBNP and potassium; Aim 2 – demonstrate a ‘factory-calibrated’ batch fabrication process for the sensors;
Aim 3 – perform at least 3 day testing in rats with a stretch goal of >10 days with >0.7 blood correlation. The
expected outcomes of this work will enable Phase 2 SBIR support to pursue both human testing, wearable
product development, and initiation of the regulatory approval process.

Public health relevance
Project Narrative The Centers for Medicare & Medicaid Services has targeted reducing heart failure hospital readmissions as a major need, and recent clinical studies have shown that these readmissions can be significantly reduced through rapid treatment up-titration after heart failure diagnosis. Unfortunately, the technological infrastructure needed to support rapid treatment up-titration is insufficient for most health-care providers. This SBIR Phase 1 project will provide initial animal demonstration of the first ever factory-calibrated continuous molecular monitor for NT-proBNP and potassium in heart failure patients, for reducing hospital readmissions and adverse events during up-titration of heart failure treatment.